Improving Diagnosis, Treatment & Detection of Drug Resistance in HIV-2 Infection

To achieve the UNAIDS 95-95-95 targets, and to eventually end the HIV/AIDS pandemic by 2030, simple, safe,
and effective antiretroviral (ARV)-regimens are needed, as well as simple and inexpensive, point-of-care devices
for HIV viral load monitoring and “real-time” access to drug resistance testing in those with virologic failure. The
global rollout of a 1st-line dolutegravir (DTG)-based antiretroviral therapy (ART) with a generic, single-tablet
regimen of tenofovir-lamivudine-dolutegravir (TLD) has the potential to significantly alter the course of the
HIV/AIDS epidemic in resource-limited settings (RLS). However, as of the end of 2022, in West/Central Africa,
home to ~4.8 million people with HIV (PWH), with ~160,000 new infections and ~120,000 deaths per year, the
UNAIDS 95-95-95 targets are lagging (80%, 76%, 69%). In West Africa, progress towards the goal of an HIV-
free generation is complicated by the fact that both HIV-1 and HIV-2 are co-circulating, each with its’ own
challenges for diagnosis, ART and clinical management. Since 2020, 1st-line ART for HIV-1, HIV-2 and dual HIV-
1/HIV-2 infection has been TLD and rollout of TLD in West Africa has had the potential to dramatically improve
the treatment landscape by providing a single potent ART regimen for all PWH including those living with HIV-1,
HIV-2 or HIV-1/HIV-2 dual infection. However, the long term effectiveness of TLD for HIV-2 and HIV-1/HIV-2
dual infection is unproven, and early data has shown the emergence of multidrug, DTG-resistant (MDR) HIV-2
in persons failing DTG-based regimens. Novel agents, including long-acting antiretrovirals, are needed to treat
HIV-2, including people with HIV-2 (PWH2) with MDR virus, which is an emerging problem not only in West
Africa but also in the United States, Europe and other locales where HIV-2 is circulating. There are critical gaps
in the care, management and treatment of people with HIV-2, especially those with virologic failure and multidrug
resistant HIV-2. The University of Washington-Senegal Research Collaboration has a greater than three
decade history of performing cutting-edge translational and clinical studies of HIV-2 care and treatment with our
Senegalese partners. For the Renewal of our current R01(AI120765) entitled “Improving Diagnosis,
Treatment & Detection of Drug Resistance in HIV-2 Infection” we propose to build on our previous work with
the following innovative SPECIFIC AIMS: AIM 1: A cohort study of long term clinical and immuno-virologic
outcomes in people living with HIV-2 and HIV-1/HIV-2 dual infection who have initiated dolutegravir-
based ART (TLD) in the Senegal National HIV/AIDS Treatment Program. AIM 2: Determination of
genotypic and phenotypic susceptibility, resistance mechanisms and pathways, of HIV-2 to novel and
pipeline antiretroviral agents. Our overarching goals are to improve care, management and treatment of
people with HIV-2.

Public health relevance
The global rollout dolutegravir-based ART with a generic, single table regimen of tenofovir-lamivudine- dolutegravir (TLD) has the potential to improve outcomes of people living with HIV-1, HIV-2 and HIV-1/HIV-2 and achieve the UNAIDS 95-95-95 targets in West Africa. However emerging evidence from people living with HIV- 1 suggest that rates of virologic failure and dolutegravir resistance are higher than expected and there is a gap in our knowledge about people living with HIV-2 (PWH2), but early data is concerning. Evaluation of the long term outcomes of TLD for HIV-2 infection in West Africa, as well as exploring pipeline antiretroviral agents against drug resistant HIV-2 will help improve the treatment landscape in PWH2.